Building Social and Structural Connections for the Prevention of OUD among Youth Experiencing Homelessness: An RCT Examining Biopsychosocial Mechanisms

Project Summary/Abstract
Homelessness severely affects health and well-being and is particularly negative for youth. Between 70-95% of
youth experiencing homelessness (YEH) report problem substance use and 66-89% have a mental health
disorder. Youth appear to be at greater risk for living on the streets or being homeless than adults and are more
vulnerable to long term consequences of homelessness. Multiple social determinants of health (SDOH) are
uniquely associated with homelessness, driving substance use and adverse mental health consequences.
However, limited research has identified pragmatic interventions that have a long-term ameliorating impact on
the complex, multi-symptomatic issues among these youth. This study overcomes prior gaps in research through
testing a multi-component comprehensive prevention intervention targeting SDOH that may affect
biopsychosocial health indicators and longer-term health outcomes. In partnership with Star House, a drop-in
center for YEH, youth between the ages of 14 to 24 years, will be engaged and randomly assigned to conditions
using a dismantling design so that essential intervention components can be efficiently identified. In particular,
youth (N = 300) will be randomly assigned to a) Motivational Interviewing/Community Reinforcement Approach
+ Services as Usual (MI/CRA + SAU, n = 80), b) Strengths-Based Outreach and Advocacy + SAU (SBOA +
SAU, n = 80), c) MI/CRA + SBOA + SAU (n = 80) or d) SAU (n=60) through the drop-in center. In order to assess
the longer-term prevention effects on substance use, mental health and other outcomes, all youth will be
assessed at baseline and at 3, 6, 12, 18 and 24-months post-baseline. The primary goal of this study is to
establish the impact of a comprehensive intervention embedded within a system that serves YEH, a community
drop-in center, on youth’s opioid misuse and disorder, other substance misuse and disorders, mental health
diagnoses, and other targeted outcomes. This study will offer unique information on pathways underlying change
for specific subgroups of youth along with cost estimates to inform future implementation efforts in drop-in centers
around the country.

Public health relevance
Project Narrative Multiple social determinants of health (SDOH) underlie the staggering negative health outcomes among youth experiencing homelessness, including a lack of stable safe housing, income, education, food security, access to services, and intervention options, as well as high levels of discrimination, victimization and social isolation. Prevention efforts addressing these SDOH and that are embedded within systems that serve youth, such as drop-in centers, may be the most promising strategy to prevent opioid use and other substance use disorders as well as homelessness in adulthood. As such, this proposal addresses a significant public health concern, and if our hypotheses are supported, the intervention may be readily transported to communities around the country.